Peptide-HLA-DQ8 biologics for antigen-specific therapy in Type 1 Diabetes

PROJECT SUMMARY/ABSTRACT
Antiger Therapeutics Inc is a startup biotech company specializing in engineering recombinant human
leukocyte antigens (HLA) and membrane proteins. In this SBIR phase I application, we leverage this expertise
to develop targeted immunotherapies for type 1 diabetes (T1D), a global health challenge affecting around 8.4
million individuals. As a chronic autoimmune disease, T1D leads to severe complications like cardiovascular
and kidney injuries, substantially reducing life expectancy by an average of 13 years. Current immunotherapies
suppress the immune system in a nonselective manner, and the associated toxicity precludes their long-term
use for T1D control. The sole FDA-approved immunotherapy for T1D, teplizumab, only delays the disease
onset for approximately two years. Antiger Therapeutics Inc aims to address this problem by selectively
targeting the abberrant immune response in T1D. One pivotal immunogenetic factor in T1D development is the
HLA-DQ8 membrane protein, which presents autoantigens such as insulin peptides to activate pathogenic T
cells and disrupt immune tolerance. Our primary objective is to specifically block the pathogenic T cells that
recognize the insulin peptide-DQ8 (pDQ8) complex, thereby safely preventing or reversing T1D. Antiger's
proposed product is an innovative biologic comprised of functional multimers of pDQ8. However, assembling
the pDQ8 complex poses technical challenges due to inefficient pairing between DQα and DQβ chains. To
overcome this problem, the company employs novel solutions involving disulfide bond engineering and the
production of full-length membrane proteins.
Antiger's recent work has demonstrated the effectiveness of
disulfide engineering in producing functional, dimeric pDQ7-Fc at increased yields.
Through structural
modeling, conserved regions in DQ7 and DQ8 were identified with the potential for disulfide bond engineering
to improve complex assembly and production yield. In Specific Aim 1, we will generate dimeric pDQ8-Fc fusion
proteins. The pDQ8 complex will be stabilized by inter-chain disulfide bond introduced by site-directed
mutagenesis to enhance the production yield; the Fc portion enables dimerization of the pDQ8 complex in an
antibody-like structure. In Specific Aim 2, we will generate pDQ8-Transmembrane proteins on detergent
micelles. The transmembrane domains of full-length α and β chains of DQ8 protein will promote the assembly
of pDQ8 complex to be solubilized on micelles. In both aims, we will assess the yield and purity of multimeric
pDQ8 proteins and measure their inhibitory effect on pDQ8-specific T cell hybridomas. By the end of this
phase I SBIR, we expect to generate one or more candidate proteins that meet pre-specified acceptance
criteria on production yield, purity, and function. Phase II plans encompass testing the biologic in humanized
murine T1D models, assessing immunogenicity and optimization, ultimately preparing for IND submission.
Commercially, Antiger intends to collaborate with or license the product to a pharmaceutical company for
further development, aiming to tap into the high-demand T1D therapeutic market, projected to be worth $24
billion by 2029. Moreover, the scalable technology holds promise for addressing other class II HLA-associated
autoimmune disorders, such as celiac disease and rheumatoid arthritis.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE STATEMENT Type 1 diabetes (T1D) is a chronic autoimmune disease affecting 1.4 million people currently in the United States. T1D often leads to cardiovascular, renal, and other serious complications, shortening the life expectancy by 13 years on average. There is currently no cure for T1D or treatment to address the immunogenetic root cause of T1D. Through this SBIR funding, we will develop a novel immunotherapy with the potential of targeting pathogenic immune cells that drive the onset of T1D, without compromising the immunity for infection and cancer control. The ultimate product of this project should significantly advance our mission to improve the well-being and lengthen life for those afflicted by this severe and prevalent disease.